Evaluation of Non-covalent Antibody Drug Complexes (ADCx) for Targeted Drug Delivery

This project proposes the development of a non-covalent antibody-based drug delivery strategy. The strategy,
abbreviated ADCx for Antibody Drug Complex, consists of an anti-drug antibody that is bound to a drug ex vivo
and targeted to a cell type of interest through a secondary affinity ligand. ADCx is designed to bypass the linker
payload conjugation step that is necessary for antibody-drug conjugates (ADCs). Despite the tremendous
interest in ADC technology, ADCs evaluated in clinical trials have a consistent difficulty: a narrow therapeutic
window. The clinical trial failure rate of ADCs is 89% and the most common reason for failure is poor efficacy at
the maximum tolerated dose. For approved ADCs, most patients experience adverse events that can cause
dose delays, dose reductions, and patient withdrawal from therapy. ADC toxicities result from off-site payload
delivery, which is primarily due to challenges associated with the linker payload. As a result, substantial
research and development efforts have been dedicated to identifying better linkers, payloads, and conjugation
sites. Linker payload optimization has proven difficult, and introducing one solution can create a new problem.
This proposal tests the hypothesis that avoiding the linker payload with ADCx is the best way to achieve safe
and effective antibody drug therapies. Our laboratory has developed a lead anti-MMAE anti-HER2 ADCx that
has been optimized using pharmacokinetic model informed antibody engineering. The anti-HER2 anti-MMAE
ADCx will be directly compared to trastuzumab-vc-MMAE ADC in a series of pharmacokinetic, efficacy, and
tolerability studies in mice. Subsequently, we will determine critical antibody and drug attributes to maximize
ADCx tolerability and efficacy. Like ADCs, the ADCx concept may be used to treat many conditions. In some
cases, we anticipate that ADCx can deliver payloads unsuitable for ADC conjugation due to a lack of reactive
sites or stability when exposed on the ADC surface. Therefore, we will discover additional anti-drug antibodies
against other payloads for application with ADCx. Priority will be given to drugs that have multiple treatment
indications, facilitating a modular approach in which the secondary targeting ligand can be easily replaced to
develop a panel of targeted ADCx. Optimization efforts will be conducted on lead anti-drug antibodies to
ensure good developability characteristics. Collectively, these efforts will lay the groundwork to establish ADCx
as a versatile drug delivery strategy.

Public health relevance
The objective of this proposal is to develop Antibody Drug Complexes (ADCx) as a new drug delivery strategy that bypasses the problematic linker payload conjugation that has impeded the development of safe and effective antibody drug conjugates (ADCs). A lead ADCx will be compared to an ADC in a series of pharmacokinetic, efficacy and tolerability studies, and these results will be leveraged to inform ADCx optimization and extension efforts. Successful completion of this research would demonstrate the feasibility of ADCx as a drug delivery strategy that can potentially treat many health conditions including cancer, autoimmunity, and infectious disease.